Cognitive Effects of Intracellular Targeted and FAD-linked Mutant Amyloid Betas

DESCRIPTION (provided by applicant): The accumulation of amyloid β peptide (Aβ) within senile plaques and the walls of cerebral blood vessels, as well as diffuse Aβ deposits is a hallmark of Alzheimer's disease (AD) pathology. Most AD-linked mutations precipitate Aβ aggregation leading to its increasing toxicity and dementia. The main goal of this study is to elucidate the relationship between cognitive deficits induced by toxic species of Aβ1-42 in mice. Though animal modelling studies demonstrate that Aβ aggregates likely mediate, at least to some extent, cognitive dysfunction in transgenic amyloid precursor protein (APP) mice, the relationship of this dysfunction to dementia in AD patients remains unclear. We hypothesize that if the mnemonic dysfunction in mice reflects underlying processes in AD dementia, then CNS expression of internal Aβ mutations that cause familial AD (FAD) should also produce a greater degree of cognitive dysfunction in mouse models then expression of wt Aβ. There is a strong scientific rationale for studying internal FAD-linked mutant Aβs in vivo. We have chosen one Aβ mutant that has already been studied in the context of APP Tg mice, E22G (Arctic). Including this mutant will enable us to benchmark our findings using a novel method of Aβ expression against existing TgAPP E22G mice. We chose a second recently reported mutant (ΔE22), based on its novelty and the fact that it was claimed to cause AD without amyloid. We have developed unique technologies that enable us to express individual Aβ peptides in the secretory extracellular pathways or in the intracellular pathways in the brains of mice. It has been proposed that intracellular Aβ causes cognitive deficits in APP transgenic mice. Because Aβ over-expression driven by APP produces both intracellular and extracellular Aβ it is very challenging to prove which form drives the cognitive deficits. By targeting Aβ preferentially into intracellular pathways we should be able to determine if intracellular Aβ results in cognitive impairment. Thus comparing effects of individual Aβ mutants should help to establish the relationship between intrinsic mutations in the Aβ sequence that cause AD and the cognitive deficits in mice. We predict that, if the cognitive deficit is a reliable surrogate for pathologic phenomena associated with AD dementia, a mutant Aβ that causes AD should result in stronger cognitive impairment then the wild-type Aβ. Such targeting studies should provide critical insight into the cascade of events where Aβ exerts its behavioural effects. Our central hypothesis is that if the behavioural deficits studied to date in TgAPP mice are relevant to the study of AD and are good correlates of Aβ pathology, then understanding the mechanisms by which Aβ induces cognitive deficits in mice, may lead to novel therapies aimed at improving cognition in humans. PUBLIC HEALTH RELEVANCE: Highly fibrillogenic and more toxic sub-form of amyloid 2 peptide (Aβ42) is implicated in neuronal death and dementia in Alzheimer's disease. We will use novel technology of expressing various mutations of Aβ42 in mouse brain and we will compare the effects of these individual Aβ mutants on cognition in mice. Our study will potentially provide a novel paradigm for performing model genetic manipulations within the brain that can be analyzed using behavioral assays. The understanding of the mechanisms by which Aβ induces dementia in mice, may lead to development of novel therapies aimed at improving cognition in humans.

Public health relevance
PROJECT NARRATIVE. Highly fibrillogenic and more toxic sub-form of amyloid β peptide (Aβ42) is implicated in neuronal death and dementia in Alzheimer's disease. We will use novel technology of expressing various mutations of Aβ42 in mouse brain and we will compare the effects of these individual Aβ mutants on cognition in mice. Our study will potentially provide a novel paradigm for performing model genetic manipulations within the brain that can be analyzed using behavioral assays. The understanding of the mechanisms by which Aβ induces dementia in mice, may lead to development of novel therapies aimed at improving cognition in humans.